Data Coordinating and Operations Center for the ECHO IDeA States Pediatric Clinical Trials Network

PROJECT SUMMARY
Eligibility for the Institutional Development Award (IDeA) program is based on historically low levels of NIH
funding. IDeA states differ from non-IDeA states with respect to the rural/urban distributions of the population
and access to medical care. Compared to children in non-IDeA states, children in IDeA states are more likely
to live in rural areas and are less likely to have access to or receive medical care. Since multi-center pediatric
clinical trial networks are concentrated in centers in non-IDeA states, there are limited opportunities for children
living in IDeA states to participate in clinical research activities.
The ECHO IDeA States Clinical Trials Network (ISPCTN) was established in 2016 with 17 clinical awardee
sites and the Data Coordinating and Operations Center (DCOC) at the University of Arkansas for Medical
Sciences (UAMS) in Little Rock, Arkansas. The objectives of the Network are to develop and implement
clinical research in the IDeA states in the ECHO priority areas: upper and lower airway disease; obesity;
neurodevelopment; pre-, peri-, and post-natal outcomes; and positive child health; and to develop capacity
within the IDeA states to conduct clinical trial research.
This proposal is for UAMS to continue to serve as the DCOC for the ECHO ISPCTN. The specific aims of
the Data Coordination and Operations Center are to
1) Provide scientific, operational, administrative and logistical infrastructure support to the ECHO IDeA
States Pediatric Clinical Trials Network (ISPCTN) to facilitate the development, implementation and
dissemination of clinical research activities in the ISPCTN; and
2) Build pediatric clinical research capacity in the IDeA states to enhance the potential for conducting
clinical trials that address health issues of relevance to children in IDeA states.
We will work collaboratively with clinical investigators at the ISPCTN sites, Project Scientists and Project
Officers at the NIH ECHO Office, and other participating NIH staff, and collaborating multicenter clinical trials
groups to design and implement studies that will address health issues that disproportionately affect rural and
medically underserved children.

Public health relevance
PROJECT NARRATIVE The Data Coordinating and Operations Center (DCOC) for the IDeA States Pediatric Clinical Trials Network will facilitate the development, implementation and reporting on multicenter clinical trials that address the health needs of children living in IDeA states. Since populations in IDeA states are disproportionately rural and medically underserved, the clinical trials findings should have implications for those populations. The DCOC will also collaborate with the clinical investigators in enhancing the clinical trial workforce to improve the environment for conducting clinical trials in the IDeA states.